Research and Data Analysis Core

The embedded research project is core to the LHS scholar’s education in PERLHS, and supporting
the research project is the mission of the Research and Data Analytics Core (RDAC). The projects
will vary by where in the learning cycle the scholar chooses to specialize. While the foci differ, the
research cycle within each project is similar: articulate a problem/hypothesis; articulate a protocol;
assemble a team; gain permissions; implement an intervention(s); collect data; analyze data; and
disseminate. The RDAC will support each phase of any type of study, and the PERLHS RDAC has the
resources to do so. The RDAC will assemble the resources needed across a research project’s life
cycle. The RDAC will provide the scholars with coherent and consistent access to the many data and
analytic resources within the Johns Hopkins environment and will help the scholar to apply solid
project management methodology. RDAC will marshal the many rich resources, both human and
computer-based, to support each phase of the scholar’s research project. The RDAC leadership will
work with each scholar to assess his/her needed resources and make the necessary connections
including to data, specialized expertise, and the Biostatistics, Epidemiology, Analytics, and Design
Core. As the scholars complete their work, the RDAC leadership will assist them in depositing their
work into a searchable library of projects, indexed with appropriate metadata. An innovative part of
the RDAC will be to create, identify, catalogue, and facilitate the dissemination, implementation, and
use of scientiϐic information produced by the CER/PCOR projects and to ensure that these research
products join the emerging ecology of computable knowledge resources. Scholars, too, will leave the
program aware of the ecology beyond the local site. At the end of one year, scholars will have
completed successful projects, and will have learned state-of-the-art methods in connecting
research plans to infrastructure. Additionally, they will leave behind a Findable, Accessible,
Interoperable, and Reusable (FAIR) repository that can help future scholars within and outside of
this institution.